User-Centered Design of a Proactive RF-Based Wearable Bladder Monitor for Toilet Training of Children with ASD/IDD

Abstract
Urinary incontinence (UI) and difficulties with toilet training are significant and common challenges faced
by children and young adults with autism spectrum disorder (ASD) and/or intellectual and developmental
disabilities (IDD). For these individuals, toileting problems can result in slower progress and lower overall success
rates with toilet training compared to their neurotypical same-aged peers, and often having substantial negative
impact their independence and ability to participate in educational and community settings. Unfortunately for
many, these difficulties with incontinence can continue into adulthood, creating physical and psychological quality
of life barriers, such as physical discomfort, social isolation, improper hygiene, and lowered self-confidence and
independence. The available support tools for children struggling with toilet training have not advanced
significantly in decades, and there is an urgent need for approaches to help these individuals achieve long-term
successful toileting. In this work, a technological support tool is proposed that will provide a proactive solution to
help with toilet training. By proactively alerting before an accident occurs, it is expected that the user will be able
to learn to recognize and attend to the sensation that triggers the alert. Further, a proactive response will reduce
accident risk, minimize associated embarrassment from accidents, and decrease the likelihood of developing
toileting averse behaviors. The project takes a multi-disciplinary approach, combining expertise from Electrical
Engineering and Special Education, in order to tackle two key aims. The first aim is to identify the highly
population-dependent set of needs and constraints for an ideal toileting support tool through engagement with
key stakeholders (including parents or caregivers of children with ASD/IDD, and care providers, educators, and
clinical professionals), through focus groups and survey-based questionnaires. The second aim is to design,
implement, and pilot test a user-centered bladder monitor that aims to uniquely provide a support tool to
proactively alert of bladder fullness and support dignity and independence for children and young adults
with ASD/IDD, and others suffering from UI. Built based on radio-frequency (RF)-based technology, the
bladder monitor will be non-invasive and enable real-time, safe, and continuous measurement and monitoring of
the bladder state through a sensor array that is flexible, discreet, and wireless. The resulting monitor will meet
the diverse needs of this population, and will be the first tool ever to provide a proactive alert when the bladder
is approaching full, to support toilet training and to avoid accidents. Initial validation testing will be conducted
through electromagnetic computational simulations and experimental demonstrations, followed by pilot testing
with to establish real-world feasibility and social validity, with expanded behavioral studies in individuals with
ASD/IDD who have difficulties with toilet training planned subsequently. Long-term, this device is envisioned to
support the transition to independence for children and young adults with ASD/IDD from diverse backgrounds,
for them to achieve a higher quality of life, and greater participation in educational and community settings.

Public health relevance
Project Narrative This project will develop a radio-frequency-based monitor that uniquely provides proactive alerts of bladder fullness as a support technology for toilet training for children and young adults with ASD/IDD. The monitor will be discreet and wearable, and designed to meet the needs and constraints of this diverse population. This proactive sensing approach will assist in the transition to independence for these individuals suffering from urinary incontinence, and help them achieve a higher quality of life and greater participation in educational and community settings.